Core B: Administrative and Data Management Core

Project Summary/Abstract
The Administrative and Data Management Core will provide coordination and oversight of all activities of
the Projects and Cores in this Program, and will maximize interactions and potential synergies among Project
Leaders, Core Leaders, and laboratory personnel at the three participating institutions: Columbia University
Irving Medical Center (CUIMC), Memorial Sloan Kettering Cancer Center (MSKCC), and Weill Cornell Medicine
(WCM). The major scientific functions of the Core will be to provide expert support for data management,
biostatistics, and resource sharing for the Projects and Core A. In addition, to facilitate program integration and
effective communication among its various members, the Core will organize monthly meetings composed of two
parts: (i) Research presentations, which will include all program participants, as well as relevant Internal Advisory
Board members; and (ii) Executive meetings, which will be limited to the Executive Committee (Drs. Shen, Abate-
Shen, Sawyers, and Loda) and members of the Internal Advisory Board. The latter meetings will provide a forum
for candid assessment of research progress, oversight of Core utilization, prioritization of resources and
objectives, and resolution of potential conflicts. In addition, the Data Management component will organize
monthly meetings of the computational biologists on all Projects and Core A to ensure effective integration of
single-cell sequencing data. An important function of the Core will be to provide logistical support through
management of data and resources, fiscal review and budget analysis, preparation of progress reports, and
regulatory compliance. Finally, the Core will organize an annual full-day review of the Program Project by
members of the Internal and External Advisory Boards, who will provide detailed feedback on research progress
and future directions, as well as advice on program management.
This Core will have the following specific aims: (1) Data management for the Projects and Core A, which
will be led by co-Investigator, Dr. Aristidis Floratos (CUIMC); (2) Biostatistical support for the Projects and Core
A, which will be led by Dr. Glen Heller (MSKCC); and (3) Program management, which will include: (a)
Coordination of the overall program by maintaining the organization of the program and establishing mechanisms
for effective interaction among its personnel; (b) Data and resource sharing by promoting effective utilization of
Core A, and by facilitating data and resource sharing with external laboratories, including access to complex
mouse strains through the Jackson Laboratory; (c) Review of the Program Project by Internal and External
Advisory Boards to evaluate ongoing progress of each Project, review the functionality of the Cores, and provide
advice on future research directions. Taken together, the operations of the Administrative and Data Management
Core will ensure the smooth and efficient functioning of the overall Program, as well as planning and oversight
for its operations, and will promote the sharing of data and resources within the Program Project as well as with
external investigators.

Public health relevance
Project Narrative The Administrative and Data Management Core will provide coordination and oversight of all activities of the Projects and Cores in this Program, will maximize interactions and potential synergies among Project Leaders, Core Leaders, and the laboratories, and will foster the sharing of data and resources among Project investigators and with the external community.